Identifying molecular pathways in childhood asthma pathogenesis by integrating newborn metabolic profiles and GWAS data

PROJECT SUMMARY
Childhood asthma is a common, burdensome disease for which there are currently no effective prevention
strategies. This is due in part to our limited understanding of the molecular determinants of asthma pathogene-
sis. As the development of asthma is highly influenced by genetic and environmental factors, assessment of
both genetic and metabolomic profiles can improve our understanding of disease pathogenesis and identify
potential targets for treatment and prevention. The overall research objective of this proposal is to elucidate
metabolic and upstream genetic pathways underlying childhood asthma pathogenesis. Our central hypotheses
are that metabolic profiles at birth are associated with subsequent development of childhood asthma and that
this association is due in part to the effect of genetic variants on intermediate metabolic profiles and childhood
asthma. To test these central hypotheses, we will pursue the following specific aims: 1) identify metabolic pro-
files at birth associated with the development of childhood asthma, and 2) determine the genetic contribution to
variation in metabolite concentrations at birth and identify genetic pathways linking metabolic profiles at birth
with childhood asthma. To achieve Aim 1, we will capitalize upon a unique resource of longitudinal birth co-
horts with newborn metabolic data and rich phenotypic data (n=6209 children). To achieve Aim 2, we will utilize
genotypes for children within the largest of these cohorts to perform a metabolite genome-wide association
study. We will then leverage these findings, along with summary statistics from the largest GWAS of childhood
asthma performed to date, to perform a genetic co-localization analysis.
The purpose of this K01 proposal is for Dr. Snyder to build on her prior training in maternal-child health epide-
miology and experience with utilizing metabolomics data in large epidemiologic studies by taking on leadership
roles in the conduct of epidemiologic studies, applying modern statistical methods for high-dimensional data,
and receiving advanced training in genetic epidemiology so that she can more effectively address fundamental
questions about upstream pathways of disease development. Through the comprehensive career development
plan applied directly to the research, the complementary expertise of the mentorship team, and an outstanding
institutional environment, Dr. Snyder will acquire the knowledge, skills, and resources necessary to advance
her toward her long-term career goal of becoming a recognized leader in maternal-child health epidemiology,
with a focus on integrating genetics and metabolomics in large epidemiologic studies to understand and pre-
vent childhood respiratory diseases. The experience, training, and findings generated through this proposal will
result in Dr. Snyder developing critical research skills to move toward independence and the submission of a
highly competitive R01 application.

Public health relevance
PROJECT NARRATIVE Despite the significant public health burden of childhood asthma, no effective prevention strategies currently exist; this is due in part to our limited understanding of the molecular determinants of asthma pathogenesis. This proposal aims to elucidate metabolic and genetic pathways underlying childhood asthma pathogenesis. Successful completion of these a priori formulated research questions and the application of rigorous study designs and analyses will provide important insights on the role of metabolic dysfunction in the development of childhood asthma, identify novel metabolic and gene targets that confer differential disease susceptibility, and advance our understanding of disease pathogenesis.